Johns Hopkins Education and Research Center for Occupational Safety and Health (JHU ERC)

PROJECT SUMMARY/ABSTRACT – JOHNS HOPKINS ERC OVERALL
Situated in the largest, most highly ranked school of public health in the world, the Johns Hopkins Education
and Research Center for Occupational Safety and Health has a mission to provide cutting-edge
interdisciplinary academic and research training and continuing education in occupational safety and health
and to serve the needs of federal region III (Maryland, Washington, D.C., Virginia, West Virginia, Delaware,
and Pennsylvania), as it has done for the past 45 years. The overarching goal of the Johns Hopkins ERC is to
build critical capacity in (a) trained personnel in key areas of occupational safety and health through
multidisciplinary education and training, (b) improved skills and knowledge of practicing occupational safety
and health professionals through continuing education programs, and (c) occupational safety and health
research, with the ultimate goal of protecting the safety and health of all workers. Interdisciplinary training is
offered to masters’ and doctoral students in Occupational and Environmental Hygiene, Occupational Injury
Epidemiology and Prevention, Occupational Epidemiology and Biomarkers, and Occupational Health
Psychology, as well as to through our Occupational and Enviornmental Medicine Residency. The ERC aims to
increase the knowledge, skills, and abilities of practicing occupational safety and public health professionals to
function effectively in complex occupational settings, and to meet community needs by developing and
supporting continuing education and outreach activities, including short courses, online educational modules,
seminars, and conferences. The ERC also aims to enhance the research training capacity within our region by
funding novel pilot projects with an emphasis on creative exploratory prevention/intervention and translation
projects that are relevant to the National Occupational Research Agenda. Since its establishment in 1977, the
Johns Hopkins ERC has evolved in response to changing demands in the field, as well as to scientific and
technological advances that impact occupational safety and health practice, research, and education, while
retaining steadfastly its commitment to an integrated, interdisciplinary approach to training researchers and
practitioners. Each year, our Center’s Outreach and Continuing Education efforts serve hundreds of
organizations within our region alone, including private-sector businesses (e.g., pharmaceutical, poultry,
healthcare, food), nonprofit and academic organizations, government agencies (local, state, federal), and the
military. The outcomes enabled by the JHU ERC include: (1) our highly trained ERC graduates are placed in
relevant occupational safety and health positions in industry, academic institutions, government, health care, and
professional associations, and our alumni make exceptional and significant contributions to research-to-
practice efforts in the field of occupational safety and health; (2) skills enhancement for occupational safety and
health professionals who are prepared to address emerging threats to workforce health; and (3) research
results disseminated to key stakeholders through publications, presentations, and outreach.

Public health relevance
PROJECT NARRATIVE – JOHNS HOPKINS ERC OVERALL Situated in the largest, most highly ranked school of public health in the world, the multidisciplinary Johns Hopkins Education and Research Center for Occupational Safety and Health prepares occupational safety and health professionals in the areas of research, education, practice, and policy development, and provides outreach and continuing education in occupational safety and health. Since its establishment in 1977, the Johns Hopkins ERC has evolved in response to changing demands in the field, as well as to scientific and technological advances that impact occupational safety and health practice, research, and education, while retaining steadfastly its commitment to an integrated, interdisciplinary approach to training researchers and practitioners. The Center addresses ongoing and emerging issues, thereby building the national capacity to provide care, set policy, design and manage safety and health programs, and conduct research to further the National Occupational Research Agenda and advance the body of knowledge in this field—and as the only ERC in federal region III, which includes Maryland, Washington, D.C., Virginia, West Virginia, Delaware, and Pennsylvania —we are dedicated to meeting regional as well as national and international needs, and our center’s Outreach and Continuing Education efforts serve hundreds of organizations each year within our region alone, including private-sector businesses, nonprofit and academic organizations, local, state, and federal government agencies, and the military.